Understanding the Role of Nucleosome Turnover in the Malaria Parasite

DESCRIPTION (provided by applicant): Malaria remains one of the most deadly infectious diseases in the world. To identify new therapeutic strategies, we must gain a comprehensive understanding of how the malaria parasite regulates its complex life cycle. The goal of this proposal is to elucidate the mechanisms that orchestrate chromatin restructuring. More specifically, we explore whether nucleosome positioning, occupancy and turnover direct developmental programs over the course of the parasite infectious cycle. There is growing evidence that the epigenetic state of chromatin plays a role in parasite gene expression and pathogenicity. Whereas histone levels in most eukaryotes remain fairly constant across the cell cycle, we have found a histone crash precisely at the most transcriptionally active stage of the parasite erythrocytic cycle. Accordingly, we hypothesize that the unique manner in which P. falciparum regulates histone turnover and positioning may control the parasite gene expression in a specific manner. Using two complementary methods, we will measure histone-free and histone-bound DNA content across the parasite life cycle. DNA-enriched regions will be analyzed using next generation sequencing technology (Illumina(R)). Results will generate maps of open and closed chromatin regions that will be correlated with steady state mRNA patterns. To determine whether histone post-translational modifications regulate histone turnover, we will use a mass spectrometry approach. Stage-specific histone marks will be validated by ChIP-seq experiments. Further mass spectrometry and functional genomic studies will then be used to determine the chromatin-remodeling complexes that are involved in regulating histone turnover. Using these independent data sets, we seek to explore a connection between histone positioning, histone post-translational modifications and the parasite transcriptome. Revealing the molecular mechanisms that control histone turnover will not only allow us to find new ways to interfere with waves of transcriptional expression but will also transform our perceptions of the molecular mechanisms controlling the parasite transcription at the chromatin level and provide signposts for new anti-malarial therapies. PUBLIC HEALTH RELEVANCE: The goal of this proposal is to elucidate the mechanisms that orchestrate chromatin restructuring. The proposed research explores whether nucleosome positioning, occupancy and turnover direct developmental programs over the course of the parasite infectious cycle.

Public health relevance
Narration The goal of this proposal is to elucidate the mechanisms that orchestrate chromatin restructuring. The proposed research explores whether nucleosome positioning, occupancy and turnover direct developmental programs over the course of the parasite infectious cycle.